Ukraine HIV Research Training Program/Aging Supplement

PROJECT SUMMARY/ABSTRACT
Limited knowledge exists about aging among people living with HIV (PLWH) in the Eastern European and Central
Asia (EECA) region including Ukraine which is experiencing armed conflict. The intersection of HIV-aging with
aging-related noncommunicable diseases (NCDs) and physical performance, function and activity has never
been estimated in Ukraine and the EECA, and not evaluated among PLWH who are living to older ages. This
must be characterized in PLWH and repeatedly assessed across the HIV care continuum to ensure quality of
life among PLWH who are reaching ages older than ever observed. This application is a supplement to the
ongoing Fogarty HIV Research Training Grant. We will train one Early Stage Investigator (ESI) by
accomplishing two Aims. Aim 1 includes advanced didactic training in HIV-aging and Gerontology via two well-
established (one NIH-funded) programs in the US plus additional activities. Aim 2 includes collecting pilot data
on key aging metrics in addition to sociodemographic and HIV variables including HIV viral load and CD4+ count.
The ESI will assess physical performance, function and activity using 1) the WHO International Classification of
Functioning, Disability and Health; 2) components of the Short Physical Performance Battery, including hand
grip strength, 4-meter walk, and chair stands; and 3) the WHO Global Physical Activity Questionnaire. The ESI
will also assess NCDs, including obesity; hypertension; blood lipid, glucose and HbA1c levels; diabetes,
cardiovascular disease; and mental health NCDs including depression, post-traumatic stress disorder, and
alcohol and substance use disorders. Our ESI training plan supports implementation of our pilot study, with the
hypothesis is that the prevalence of lower physical performance, function and activity, will be observed among
PLWH who have higher levels of NCDs. This will be exacerbated among PLWH who are poorly controlled,
injection drug users, older, and men, and experience war related trauma. This innovative combination of
advanced didactic plus hands-on research training in HIV-aging of one Ukrainian ESI is the first in Ukraine and
the EECA. Among older PLWH we will use standardized and validated clinical approaches to assess HIV-aging
in combination with NCDs and HIV-related factors. This training is achievable in one year. Pilot study results will
inform development of interventions to 1) address chronological aging together with the HIV/NCD care continuum
among PLWH in Ukraine, and 2) provide a foundation for prospective observational studies of aging processes
in PLWH in Ukraine. This will build on the parent D43 and is in alignment with the theme of addressing the
humanitarian crisis sparked by the war.

Public health relevance
PROJECT NARRATIVE Aging-related decline in physical performance, function and activity, against a background of noncommunicable diseases (NCDs) is common among people living with HIV (PLWH) who are >40 years old and may engage in harmful lifestyles that exacerbate aging outcomes. This combination of factors leads to poorer HIV-aging. These facets of HIV-aging are virtually unknown globally, and especially in low- and middle-income countries in Eastern Europe and Central Asia including Ukraine, where we propose to train one Early Stage Ukraine investigator using didactic methods and hands-on pilot research project implementation.